Astrocyte-mediated regulation of cocaine-generated synapses during cocaine seeking

Abstract: Substance use disorder (SUD) is a complex emotional and motivational disorder with no effective
treatment thus far. Currently, the United States is in the midst of a SUD epidemic that defies socioeconomic
and generational boundaries. A particularly insidious component of SUD is relapse, which is the strong
motivational drive to seek drugs during abstinence. Cue-induced drug seeking is a rodent model of relapse,
wherein a drug-associated cue is presented in the absence of the drug to trigger quantifiable seeking behavior.
Addiction research attributes drug-seeking behaviors, such as cue-induced drug-seeking following self-
administration (SA) of cocaine, to altered function of the nucleus accumbens (NAc). Focusing on the NAc,
extensive studies have examined drug-induced adaptations in GABAergic, medium-spiny neurons (MSNs),
which are the majority cell type (~90%) and principal functional output of the NAc. In contrast, much less is
known about how glial cells, such as astrocytes, shape drug-related behaviors. Astrocytes closely associate
with synapses, allowing them to directly monitor and regulate synaptic transmission. The astrocyte-synapse
association (referred to as the tripartite synapse) plays a key role in experience-dependent synaptic
adaptations associated with learning and memory. Thus, the objective of this application is to characterize how
astrocytes regulate synaptic dynamics in the NAc Shell (NAcSh), which, in turn, regulate cue-induced cocaine
seeking in the mouse SA model. Prior results show that re-exposure to cocaine-associated cues re-silences
cocaine-generated NAcSh synapses, a process which contributes to the destabilization of cue-associated
cocaine memories upon cue re-exposure-induced memory retrieval. Preliminary results demonstrate that
functional astrocyte activity during withdrawal (WD) is necessary for the cue-induced re-silencing of cocaine-
generated synapses in the NAcSh, and that cues associated with cocaine reward increase astrocyte activity in
the NacSh. These preliminary results link astrocyte activity to the dynamic state of cocaine-generated silent
synapses and lead to my hypothesis that astrocytes regulate the cue-induced synaptic adaptations of cocaine-
generated synapses in the NAcSh which, in turn, regulate cue-induced cocaine seeking after cocaine WD. I will
test this hypothesis by pursuing two aims. Aim 1 will test the sufficiency of increased astrocyte activity to re-
silence cocaine-generated NAcSh synapses during WD. Aim 2 will expand preliminary data, which
demonstrates the necessity of functional astrocyte activity during WD for cue-induced synaptic re-silencing, by
using pharmacological and viral tools with increased temporal precision to suppress astrocyte activity
immediately prior to cue re-exposure. The expected outcome will provide a holistic understanding of how the
NAcSh regulates drug-induced behaviors by incorporating astroglia, thus revealing NAcSh astroglia as key
cellular substrates targeted by drug experience to reshape behaviors. This potential conceptual expansion may
provide novel angles to understand the cellular and circuit mechanisms underlying drug seeking and relapse.

Public health relevance
Narrative: Substance Use Disorder (SUD) is a brain disorder with increasing prevalence across socioeconomic and generational classes with no effective treatment. The objectives of the proposed research are to determine the role of an underexplored cell-type, astroglia, in the regulation of cue-induced synaptic changes and cue-induced cocaine seeking. The expected results will provide a novel angle to understanding NAc-based addictive behaviors, and a potential cellular target for treating SUD.